Home-based cardiac rehabilitation using a novel mobile health exercise regimen following transcatheter heart valve interventions (HOME RUN HITTER)

Among older adults, heart valve disease is common and often requires treatment with valve repair or
replacement. What used to require open heart surgery can now be done with less invasive transcatheter heart
valve interventions (THVIs), allowing for less morbidity and quicker recovery. However, despite the safety and
procedural success of THVIs, over one-half of patients are dead, have poor quality of life (QoL), and/or are
hospitalized 1 year after a THVI. Cardiac rehabilitation (CR) effectively mitigates these poor outcomes in
patients with cardiovascular disease, including those undergoing heart valve procedures. However, among
Medicare beneficiaries, only 25% of those undergoing a THVI participate in center-based CR (CBCR), which
highlights a significant unmet clinical need. To address this need, our long-term goal is to develop a home-
based CR (HBCR) program that extends the benefits of CR to more individuals after THVIs. Our over-arching
hypothesis is that a HBCR mobile health intervention that innovatively addresses key target health behaviors
will reduce clinical events and improve physical activity, functional capacity, and QoL after THVIs and that an
interactive delivery and longer duration of the active intervention will produce greater benefits. We propose a
multicenter randomized controlled trial enrolling 375 patients undergoing aortic or mitral THVIs who do not
intend to participate in CBCR; those who intend to pursue CBCR will be followed in a registry. Participants will
be assigned to 3 groups: control (1) vs. a HBCR mobile health intervention with hands-off (2) vs. interactive (3)
delivery. The intervention addresses key target health behaviors and includes Apple Watch (to encourage
physical activity and give reminders on healthy living) and an exercise prescription (to build strength/balance).
The hands-off and interactive delivery groups receive the same intervention, except for a video call (every
other week) with an exercise physiologist (interactive group only). Each intervention group (hands-off,
interactive) will be randomized to 12-week vs. 24-week duration of the active intervention. The co-primary
endpoints are: (1) clinical events composite (death, rehospitalization, skilled nursing facility visits); and (2)
average daily total activity counts. Key secondary endpoints: amount, intensity, consistency of physical activity;
6-minute walk distance; and QoL. We test whether the HBCR mobile health intervention (compared to control)
reduces clinical events and improves physical activity, function capacity, and QoL after THVI (Aim 1) and
whether interactive vs. hands-ff delivery (Aim 2) or 24-week vs. 12-week active duration (Aim 3) of the
intervention yields greater benefits. We also explore mediators of clinical benefit and mechanisms of behavior
change. With population aging, prevalence of heart valve disease and number of THVIs are rapidly increasing.
Overcoming disablement associated with severe valve disease requires more than simply fixing a valve; the
potential of THVIs to improve quantity and quality of life is unfulfilled without integrating CR. If successful, our
approach will optimize value of care and patient outcomes with broad implications for other patient populations.

Public health relevance
NARRATIVE While transcatheter heart valve interventions (THVIs) offer a less invasive option to treat clinically significant heart valve disease in older adults, over one-half of patients are dead, have poor quality of life, and/or are hospitalized 1 year after a THVI. While cardiac rehabilitation is effective at mitigating these poor outcomes, only 25% of patients participate in center-based cardiac rehabilitation in the year after their THVI and numerous barriers to participation exist. We propose a multicenter randomized controlled trial enrolling patients undergoing a THVI to test whether and how a home-based cardiac rehabilitation intervention that addresses key target health behaviors, leverages mobile health technology (e.g. Apple Watch to encourage physical activity and deliver reminders on healthy living), prescribes exercises to build strength and balance, and incorporates habit formation strategies to promote sustained behavior change will improve physical activity, functional capacity, and quality of life and decrease clinical events.